Pediatric COVID-19 Dashboard and Clinical Phenotypes

PROJECT SUMMARY/ABSTRACT
Pediatric COVID-19 is a major national and global public health problem. SARS-CoV-2 causes two types of
severe pediatric disease: acute COVID-19 and multisystem inflammatory syndrome in children (MIS-C). Both
acute COVID-19 and MIS-C can cause organ dysfunction and death. Children have typically experienced
milder COVID-19 illness severity than adults. However, during pandemic surges caused by the delta and
omicron variants of SARS-CoV-2, pediatric health systems struggled to support the needs of their communities
and regions. Periods of peak hospital demand were also driven by simultaneous mental health crises, staffing
challenges, and off-cycle transmission of viruses that cause disproportionate pediatric impact (e.g., respiratory
syncytial virus, RSV). In our prior work, we showed the impact of these surges on children and health systems
by surfacing information about the trajectories of pediatric COVID-19 hospitalization rates and severity
distributions as well as viral co-infection on a public dashboard and regularly presented these data to federal
decision-makers. Novel variants are likely to develop and spread. A more virulent and vaccine-resistant variant
could trigger a new surge in cases. Such a surge could again put pediatric health system function at risk and
present new pediatric clinical phenotypes of COVID-19. The overall objective of this Supplement is to make
information about the trajectories of pediatric COVID-19 hospitalization rates and disease severity and
unique pediatric COVID-19 clinical phenotypes readily available for national-level decision-making. We
will further develop computational pipelines to analyze the trajectories of pediatric COVID-19 hospitalization
rates and disease severity and extend our interactive pediatric COVID-19 severity dashboard for near-real-time
tracking of the impact of the SARS-CoV-2 pandemic. To do this, we will leverage the National COVID Cohort
Collaborative (N3C), a resource developed with funding from the National Center for Advancing Translational
Sciences (NCATS). N3C aggregates electronic health record (EHR) data from more than 70 U.S. centers. In
our prior work, we have demonstrated our ability to analyze the granular multicenter EHR data in N3C,
leverage state-of-the-art computational resources on the N3C platform, and implement analytic techniques
similar to those in this proposal. We will use these rich EHR data in N3C to accomplish the following specific
aim: 1A) maintain, extend, and disseminate an interactive pediatric COVID-19 dashboard and 1B) monitor for
and report on emergent pediatric COVID-19 clinical phenotypes. We have assembled an investigative team
with a successful track record in the field and will work in partnership with NIH leadership to address this
national and global health priority. We expect this Supplement to have a powerful and sustained impact on
COVID-19 policymaking and the outcomes of affected children by decreasing the likelihood of overwhelmed
U.S. pediatric health systems.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Like sepsis, COVID-19 is a life-threatening disease caused by infection that affects many children around the world and can frequently result in the failure of organs in the human body (for example, the lungs, heart, or kidneys). Detailed national data about the impact of COVID-19 on children over time are not readily available. In this Supplement, we will make information about the trajectories of pediatric COVID-19 hospitalization rates and disease severity and unique pediatric COVID-19 phenotypes readily available for national-level decision- making.